Immune dysfunction in ME/CFS

PROJECT SUMMARY
ME/CFS (Myalgic Encephalomyelitis/Chronic Fatigue Syndrome) remains a prevalent, serious and poorly
understood disease, impacting millions in the USA alone with problems in concentration, memory and sleep
together with musculoskeletal pain. Thus, there is an urgent need to advance our understanding of the basic
science of this disease – as an integral step towards an ultimate cure. Despite our lack of understanding of
ME/CFS, substantial evidence implicates immune dysregulation either as an underlying cause or major
consequence of the disease. Our work has sought to systematically examine gene regulation across the
immune system, with the goal of determining which components are dysregulated in ME/CFS. These studies
have identified classical monocytes, platelets and certain subsets of T cells as the components of the immune
system most severely impacted by ME/CFS. These results establish that immune dysregulation in ME/CFS
involves disparate components of the immune system. Project 3 of our ME/CFS Center has three major goals.
First, to use multiomic approaches to rigorously determine the gene regulatory changes in monocytes in
ME/CFS. To complement these approaches, we will perform monocyte assays to test whether ME/CFS results
in alterations in the ability of monocytes to migrate and differentiate into macrophages, a critical function of
monocytes. Second, we will examine platelet dysregulation in ME/CFS, as our data identifies platelets as
amongst the most dysregulated component of the immune system in ME/CFS, with dysregulation particularly
evident in patients undergoing post-exertional malaise. We hypothesize that platelet defects could contribute to
circulatory and other symptoms in ME/CFS. In this Aim, we will examine the platelet transcriptome, perform
assays to test platelet function, and examine interactions between platelets and other immune cells in
ME/CFS. Third, we will systematically identify ME/CFS specific alterations in signaling across the immune
system. This goal is important, as identification of molecular changes that impact the immune system broadly
are attractive targets for future development of therapies. Achieving these goals has the potential to improve
diagnosis, including generating biomarkers, and will identify specific dysregulated pathways in ME/CFS,
providing a foundation for future development of therapeutics. For example, our first two goals have the
potential to reveal consequential alterations in either (or both) monocytes and platelets in ME/CFS, thereby
establishing a rational path towards eventual treatments or a cure. Because the patient and control cohorts
examined are common across this Center application, we will generate synergistic data from the constituent
projects. In particular, our genomic and functional assays examining monocytes will be paired with profiling of
macrophages in muscle (Project I), which are derived from monocytes in circulation. Similarly, Project II will
examine alterations to the platelet-derived extracellular vesicle proteome in ME/CFS, complementing our
analysis of platelets. Our comprehensive data will be a key resource for all researchers in the field.

Public health relevance
A. SPECIFIC AIMS PROJECT III: Immune dysfunction in ME/CFS ME/CFS (Myalgic Encephalomyelitis/Chronic Fatigue Syndrome) remains a prevalent, serious and poorly understood disease, impacting millions in the USA alone. Our relative lack of understanding of ME/CFS makes diagnosis non-trivial and limits therapeutic interventions and innovations. The immune system is among the major systems altered in ME/CFS. Whether damage or alterations to the immune system in ME/CFS are causal or consequential is unknown, and how such alterations interact with other aspects of physiology, such as the neuromuscular system, is also poorly understood. Our work has sought to systematically examine gene regulation across many cell types within the immune system, with the goal of determining which components are dysregulated in ME/CFS. These studies have identified three immune cells most severely impacted by ME/CFS: classical monocytes, platelets and certain T cell subsets. These results are notable, as they establish that immune dysregulation in ME/CFS involves disparate components of the immune system. The major goals of this proposal are to: (i) Use genomic and computational methods to better understand the gene regulatory mechanisms that result in immune dysregulation in ME/CFS; (ii) Perform focused experimental studies on selected immune cells, such as monocytes and platelets, to better understand their alterations in ME/CFS; and, (iii) Systematically identify ME/CFS specific alterations in signaling across the immune system. Achieving these goals has the potential to improve diagnosis, including generating powerful biomarkers, and will identify specific dysregulated pathways in ME/CFS, providing a foundation for future development of therapeutics. Aim I Characterizing monocyte abnormalities in ME/CFS. Classical monocytes exhibit a pronounced signature of transcriptome dysregulation in ME/CFS, as judged by multiple criteria, including numbers of dysregulated genes, number of dysregulated pathways, and consistency in dysregulation between patients. In this Aim, we will use multiomic approaches to rigorously determine the gene regulatory changes in monocytes in ME/CFS. To complement these approaches, we will perform assays using patient and control monocytes to test whether ME/CFS results in alterations in the ability of monocytes to migrate and differentiate into macrophages, a critical function of monocytes. In parallel, we will collaborate with Project 1 of this Center to more directly link monocyte dysregulation in the blood to alterations in macrophages in muscle tissue. Aim II Investigating platelet dysfunction in ME/CFS. Platelets are cytoplasmic particles derived from megakaryocytes. Although platelets lack a nucleus, they possess a transcriptome derived from their parent cell. Our data identifies platelets as amongst the most dysregulated component of the immune system in ME/CFS, with dysregulation particularly evident in patients undergoing post-exertional malaise. We hypothesize that platelet defects could contribute to circulatory and other symptoms in ME/CFS. Although the primary function of platelets is in wound healing and coagulation, they also possess important additional functions including the ability to interact with and modulate other immune cells. In this Aim, we will comprehensively examine the platelet transcriptome, perform assays to test platelet function, and examine interactions between platelets and other immune cells in ME/CFS. To complement our studies, Project 2 of this Center will examine ME/CFS specific alterations in the proteome of platelet-derived extracellular vesicles (EVs; subcellular particles secreted by one cell that deliver biorelevant cargoes to target cells). Aim III Exploring alterations in signaling across the immune system. Substantial evidence indicates that perturbations exist across the immune system in ME/CFS, implicating involvement of intercellular signaling pathways. The goal of this Aim is to examine two possible signaling mechanisms that could contribute to immune dysregulation in ME/CFS. Identification of molecular changes that impact the immune system broadly are attractive targets for future development of therapies. Based on our Center’s data implicating EV-cargo alterations in ME/CFS, we will examine microRNA cargoes of three defined EV sub-populations: those derived from platelets, endothelial tissue and neuronal cells. Focusing on EV subtypes is essential, as it is now well established that EVs are heterogenous, in terms of cargo, cell of origin, target cell preference and function. In parallel, we will use computational approaches and single-cell transcriptomics to identify ligand-receptor alterations in ME/CFS, with cell-type resolution. The resulting inferences will be validated experimentally. This Aim will initiate a new paradigm in ME/CFS research: examining alterations in signaling across the immune system. Successful completion of our Aims will generate multiple fundamental mechanistic insights into ME/CFS. Firstly, by focusing on specific cells of the immune system, Aims I and II have the potential to reveal consequential alterations in either (or both) monocytes and platelets in ME/CFS, thereby establishing a rational path towards eventual treatments or a cure. Secondly, by performing multiomic profiling of the immune system, we will substantially expand our understanding of immune dysregulation in ME/CFS. Finally, by integrating our Aims with Projects 1 and 2 of this Center, we will extend the impact of our work, for example, by linking monocyte alterations in blood to macrophage dysfunction in tissues.